Prevention of Crohns Disease in High-Risk Individuals

PROJECT SUMMARY/ABSTRACT
Crohn’s disease (CD) is a chronic, disabling inflammatory bowel disease (IBD) associated with enormous
social and economic impact, decreased quality of life, increased mortality, and rising global incidence. Despite
the approval of numerous advanced therapies for treating CD, the therapeutic ceiling has plateaued.
Therefore, there is an unmet need to explore prevention strategies in CD. Dietary and lifestyle factors are
thought to be primary CD risk factors and may influence CD development in the pre-clinical disease phase.
CD-specific biomarkers emerge in the pre-clinical phase, predict subclinical inflammation, correlate with
disease activity, and may decrease with dietary changes. Thus, dietary and lifestyle modification may
normalize CD biomarkers and reduce disease risk. High-risk individuals such as first-degree relatives (FDRs)
of patients with IBD or those who carry genetic variants associated with CD are an attractive group for disease
prevention strategies. Our hypothesis is that lifestyle modification in individuals at high-risk for CD reduces risk
of CD development, and that personalized risk disclosure and risk factor counseling can be feasibly delivered
to FDRs via the personalized risk estimation for CD (PRE-CD) tool. To test this hypothesis, we will assess how
adherence to a healthy diet and lifestyle impacts risk for CD in FDRs (Aim 1) and those with elevated polygenic
risk scores for CD (Aim 2) from the Nurses’ Health Study (NHS), NHSII, Health Professionals Follow-up Study
and Growing Up Today Study using a target-trial methodology to emulate a randomized controlled trial of a
healthy lifestyle intervention. Second, we will develop and test the feasibility (Aim 3a) and explore the efficacy
of the PRE-CD tool on behaviors (Aim 3b) and pre-clinical biomarkers (Aim 3c) associated with CD in FDR
recruited from the Massachusetts General Hospital (MGH) Crohn’s and Colitis Center. This work will provide
valuable insight into the role of lifestyle and dietary modification in CD development and prevention strategies
in high-risk individuals, addressing a critical gap in the field of IBD prevention. Further, through the proposed
work, Dr. Lopes will gain training in the fields of nutritional epidemiology, causal inference, and conducting
clinical trials, enabling her to achieve her long-term goals of becoming an independently funded clinical-
investigator and generate preliminary data to subsequently apply for an NIH R01 award. The purpose of this
proposed supplement is to support Dr. Lopes and facilitate advancement of her research during her
upcoming period of maternity leave and the early infancy period. Such support will ensure continued
progress of Dr. Lopes’ career goals toward research independence.

Public health relevance
PROJECT NARRATIVE In spite of significant advances in medical therapeutic options for Crohn’s disease (CD), there are currently no strategies for prevention of this chronic, disabling inflammatory disease. The parent K23 award supports Dr. Lopes’ project to delineate the impact of dietary and lifestyle modification on preventing CD development in high-risk individuals, and conduct the first interventional study to assess the feasibility and effect of personalized risk disclosure and risk-factor counseling as a tool to reduce behaviors and biomarkers associated with CD development in unaffected first-degree relatives. The proposed supplement will provide the support necessary for additional personnel to advance research on the parent award during Dr. Lopes’ upcoming period of maternity leave and the early infancy period and facilitate her continued progress toward research independence.